HiTIF Microscopy Core Facility

The HiTIF is currently involved in 31 collaborative projects with NCI intramural Research Investigators. The current HCI projects run at HiTIF cover many different basic research areas that are important for cancer research: - DNA Damage Response (DDR) - Chromosome Instability (CIN) - Epigenetics of DNA translocations - Nuclear hormone biology and regulation of gene expression - RNA splicing - Premature aging disease - Liver cancer initiation mechanisms - Immuno Oncology. The HiTIF is open to assist NCI and NIH investigators in the design, optimization, implementation and analysis of High-Content Imaging assays for the systematic study of cancer-relevant cellular phenotypes